Refinement of a Training Module to Improve Discussions of Sexual Orientation and Gender Identity in Cancer Clinics

PROJECT SUMMARY/ABSTRACT
Sexual and gender minority (SGM) individuals comprise a growing population of over 20 million people in the
United States. SGM individuals experience cancer care-related disparities with comparatively more frequent
late-stage cancer diagnoses and more premature cancer deaths. Although these disparities are stark, the
cancer-specific needs of SGM patients are under-reported and under-studied. Our preliminary data reveals
that fewer than half of oncology practices nationwide collect SOGI data, because oncology clinicians lack
training in how to discuss SOGI information in an affirming and culturally appropriate manner. Invisibility of
SGM people further exacerbates cancer-related disparities; clinicians and researchers cannot even begin to
discuss ways to improve these patients’ cancer care without first identifying them and their cancer-specific
needs. We propose to remedy this by refining a training module for oncology clinicians, which will teach
clinicians why and how to ask patients about their SOGI status in cancer clinics. In the first aim, we propose to
pilot this training module among oncology clinicians at three clinical sites nationwide. We will learn oncology
clinicians’ views and attitudes of this module and feelings of competence in caring for SGM people after
participating in this module, using qualitative interviews. Interview questions will be derived from a model
highlighting five fundamental constructs to provide culturally responsive healthcare to diverse groups of
patients, developed by Campinha-Bacote and colleagues. We will use an iterative process to improve the
module content, based upon this qualitative data. In the second aim, we propose to learn the views and
attitudes of SGM patients about the training module content using qualitative interviews, and, based on this
data, further refine the module so that it is as patient-centric and SGM-affirming as possible. Upon completion
of these aims, the final training module will be: 1) concise and thereby easily implementable into clinical
practice – it will take 45 minutes or less to complete, 2) specifically targeted to both patient and clinician
concerns and needs, 3) applicable to a wide and diverse audience. With the completion of these two aims, the
finalized module will be ready for further development within the context of a national clinical trial and ready for
broad dissemination among oncology practices.

Public health relevance
PROJECT NARRATIVE Sexual and gender minority (SGM) individuals are often diagnosed with late-stage cancer and often die from cancer prematurely; however, the cancer-specific needs of SGM people are under-reported and therefore under-studied. Our preliminary data reveals that oncology clinicians’ reluctance to ask about sexual orientation and gender identity is a root cause for the lack of systematic collection of SOGI information. This R03 application will enable the principal investigator to refine a concise, innovative training module for oncology clinicians focused on why and how to ask about patient sexual orientation and gender identity in cancer clinics, based directly upon formative clinician and SGM patient feedback, with an ultimate goal to improve affirming cancer care for SGM people.